Clinical Studies

PROJECT SUMMARY: CORE B
The proposed Center for Excellence in Translational Research combines four projects focused on developing a
rapid molecular diagnostic to detect altered drug responses to Mycobacteria tuberculosis (Mtb). Core B, our
proposed clinical research core, will support projects involving human subjects. We will build on systems and
expertise that we have developed in previous work to provide services that include developing protocols to
ensure all aspects of human subjects research meet NIH requirements; that all procedures and materials are in
place for data management, quality control, storage and analysis; that data collection protocols are being
implemented; that staff are trained in the research and understand its goals; and that specimen collection and
clinical procedures are standard across sites.

Public health relevance
RELEVANCE: CORE B By supporting human subjects research including data collection and analysis of this CETR, Core B will contribute to the development of a rapid molecular diagnostic to detect altered drug responses to Mtb and enable early diagnosis and appropriate treatment of drug-resistant TB.